Use of a non-human primate model to define the role of T cell immune responses in persistent Kaposi sarcoma-associated herpesvirus infection and Kaposi sarcoma pathogenesis

PROJECT ABSTRACT
Kaposi sarcoma-associated herpesvirus (KSHV) is the causative agent of several human malignancies including
Kaposi sarcoma (KS). KS is the most common KSHV-associated malignancy, with >44,000 new cases reported
worldwide each year. The population most vulnerable to KSHV/KS are immunocompromised individuals such
as people infected with HIV. Individuals with HIV/AIDS have a higher risk of developing KS when compared to
HIV-negative individuals. The adaptive T cell immune response, especially CD4+ and CD8+ T cells, has been
shown to play a crucial role in KSHV infection and subsequent KS pathogenesis. Although correlations between
CD4+ and CD8+ T cell levels and KS development have been observed, this relationship has not been
experimentally validated due to the lack of a suitable animal model. The recent development of the common
marmoset (Callithrix jacchus) as a non-human primate (NHP) model that is susceptible to KSHV infection and
capable of developing KS-like lesions under immunosuppression opens new frontiers to experimentally validate
the role immune cells play in KS development. Thus, our objective is to define the role of reduced CD4+ and
CD8+ T cell levels in persistent KSHV infection and subsequent KS pathogenesis in the marmoset NHP model.
Anti-CD4 and anti-CD8 monoclonal antibodies (mAbs) have been used to deplete T cells and induce
immunosuppression in both murine and NHP animal models, enabling study of CD4+/CD8+ T cells in controlling
replication of several viruses. To avoid any adverse responses to murine mAbs when administered into
marmosets, we will chimerize (murine-marmoset) anti-CD4/CD8 mAbs and characterize their biochemical and
pharmacokinetic properties in vitro and in mice, then we will determine the effects of antibody-mediated T cell
depletion on various immune cell populations (Aim 1). We will then challenge immunosuppressed marmosets
with KSHV.219 virus and determine the extent to which antibody-mediated depletion of CD4+ and/or CD8+ T
cells enables persistent KSHV infection and KS pathogenesis in immunocompromised marmosets (Aim 2). The
successful completion of this project will validate the common marmoset as a tool for understanding the etiology
of KS and uncover the critical role that CD4+ and/or CD8+ T cell depletion plays in allowing persistent KSHV
infection and subsequent KS pathogenesis in immunocompromised animals.

Public health relevance
PROJECT NARRATIVE Kaposi Sarcoma (KS) is a cancer caused by Kaposi sarcoma-associated herpesvirus (KSHV) and is very common in individuals with HIV/AIDS. Weakening of the immune system is thought to play a role in allowing KSHV infection to occur and KS to develop. We propose to use common marmoset monkeys to demonstrate that the removal of immune cells allows KSHV infection and KS development.